PHARMACOKINETICS OF CEFTRIAXONE IN PATIENTS WITH CIRRHOSIS AND ACITES

The study will compare the pharmacokinetics of ceftriaxone in patients with cirrhosis and ascites with normal volunteers and assess ascitic fluid penetration of the antibiotic.